Identification of Brain Circuits Underlying Fear and Panic

Objective: The objective of this proposal is to train Dr. Aubrey Chan, MD/PhD, dual-boarded in internal
medicine and psychiatry, to become an independent VA physician-scientist. He will be mentored in state-of-
the-art neuroscience research techniques in recording neural signals by his mentors Drs. Rainbo Hultman and
Nandakumar Narayanan, and he will be mentored in the cutting-edge analytical techniques applied to these
signals by Dr. Matthew Howard. Dr. John Wemmie will serve as the career development mentor, providing
guidance in Dr. Chan’s development as a principal investigator, managing lab personnel, mentoring graduate
students, scientific communication, and grantsmanship.
These research techniques will be applied to a novel, circuit-wide analysis of defensive responses by
recording from and analyzing signals of multiple brain regions simultaneously. Defensive responses are
physiological, emotional, and behavioral changes that occur when an organism is faced with a threat.
Excessively active or exaggerated defensive responses underlie psychiatric illnesses like post-traumatic stress
disorder, an illness that is highly prevalent in the veteran population, and which causes tremendous distress,
disability, and suicide in veterans. Defensive responses will be studied in mice in response to carbon dioxide
(CO2), a naturalistic stimulus which represents the interoceptive (internal) threat of suffocation. This threat will
be compared and contrasted with exposure to trimethylthiazoline (TMT), a component of fox odor, representing
the naturalistic but exteroceptive (external) threat of a predator. Responses will be analyzed both in a naïve
state and after animals are exposed to a traumatic, chronic social defeat stress (CSDS).
Dr. Chan will also dedicate time to the clinical care of veterans. Being dual-trained in internal medicine and
psychiatry, he is particularly suited to treating the complex comorbid conditions often seen in veterans. He will
work on the inpatient psychiatric unit and the psychiatric consult-liaison service at the Iowa City VA Medical
Center.
Methods: Custom electrodes will be constructed and stereotactically implanted into multiple mouse brain sites.
After recovery from surgery, awake, behaving mice will be exposed to threatening stimuli while neural
recordings are performed. Aim 1 will study the effects of CO2 and TMT in naïve animals, with follow-up
exposures after animals have undergone CSDS. Behaviors will be matched against neural signals. Neural
signals will be evaluated for local field potential (LFP) power, firing rates of individual neurons, and for
functional connectivity measures between brain sites. In addition, the bispectral & electome methods will be
used to detect salient neurophysiological features that predict behaviors. Aim 2 will use optogenetic
manipulation of neural signals to modify defensive behaviors. To facilitate these studies, Dr. Chan will take
coursework in automated behavioral scoring and statistical analysis.
Expected Results: The proposal will have these main outcomes: 1) it will establish a foundational map of the
defensive response brain circuit in both naïve mice and mice that have undergone social defeat stress. 2) by
comparing CO2 threat and TMT threat, it will also establish which neural mechanisms are shared and which
are unique to specific threat modalities. 3) it will identify neurophysiological features that predict animal
behavior and test causality by manipulating neural signals to alter behavior. 4) The mentorship of Dr. Howard
will enable rapid translation of these findings into studies in neurosurgical human subjects, accelerating the
development of potential therapies for veterans. 5) It will establish the applicant as an expert in the field of
network neurophysiology related to PTSD and propel him forward in his career as a VA physician-scientist.

Public health relevance
Post-traumatic stress disorder (PTSD) afflicts many veterans and results in distress, disability, and suicide. PTSD is characterized by the inappropriate and/or excessive activity of defensive responses. Defensive responses are normally adaptive changes in physiology and behavior that maximize an organism’s safety when faced with a threat; however, excessive activation of defensive responses lead to maladaptive behaviors. This proposal aims to understand the brain physiology underlying defensive response by mapping and decoding the neurophysiological signals across multiple brain sites and the connections between these sites in response to multiple threat stimuli. Naïve animals are exposed to threat both before and after a traumatic social defeat stressor to determine how this stressor affects the responses to threat. Optogenetic manipulation of neural signals is used to modify behavior. The overall goal is to understand how the brain controls these behaviors and to find potential targets for intervention in the treatment of illnesses like PTSD.